Investigating the relationship between availability of neighborhood resources and mentalizing

Modified Project Summary/Abstract Section

More than 10 million youth in the United States live in poverty and lack access to neighborhood and material resources. Experiences associated with poverty and neighborhood resource scarcity are well known to confer risk for adverse mental health outcomes in part by shaping neural structure and function. At the same time, brain development is highly plastic and shifts to meet the needs of the environment. Despite emerging research finding behavioral and neural differences between adversity and non-adversity exposed youth – differences that reflect adaptive developmental processes – few research studies have explored the processes that develop to support youth in navigating environments marked by resource scarcity. For individuals who lack material resources, cognitive processes are likely to be shifted towards meeting the environmental challenge of obtaining those material resources needed for day-to-day survival. One way in which individuals impacted by resource scarcity achieve this is through forming, utilizing, and maintaining social relationships. Social relationships provide a range of resources, including social capital and social support. Underlying the maintenance of supportive social relationships is mentalizing– the ability to understand and take the perspectives of others’ thoughts and emotions. Based on available evidence, we hypothesize that increased engagement in mentalizing serves as a protective factor against psychopathology for adolescents who lack access to neighborhood and material resources. The proposed project will leverage a multi-modal longitudinal study to examine the impacts of neighborhood resource availability on mentalizing, cognitive empathy, and associated neural correlates that may support the acquisition of social support and promote positive mental health outcomes. Three aims guide this research: (1) exploring how availability of resources impacts mentalizing, associated neural networks, and cognitive empathy, (2) examining how mentalizing supports the maintenance of social support, and (3) evaluating mentalizing and cognitive empathy as an underlying protective mechanism against psychopathology among youth who lack access to neighborhood and material resources. These aims will be addressed by leveraging a large study of adolescent youth (expected n = 275) who will participate in a passive neuroimaging task and complete behavioral and self-report measures. Resources that will support this research include access to this longitudinal sample, multiple research facilities, and a strong mentorship team with expertise in developmental neuroscience and resilience. The proposed research will enrich theories regarding how neurodevelopmental processes are shaped by the environmental experience and identify protective factors that can be leveraged to inform mental health treatments.

Public health relevance
Modified Public Health Relevance Section This project aims to investigate whether mentalizing abilities emerge as a cognitive strength and protective factor among youth living in environments characterized by a lack of neighborhood and material resources. Results from this study will improve knowledge of the way neural function and cognition is shaped by the environment and will help identify protective factors that can be leveraged to promote positive mental health outcomes.